tRNA Processing

ABSTRACT
tRNAs are highly evolved in all organisms for specific recognition by cognate tRNA synthetases, accurate
decoding, efficient use in translation, flexibility, and stability. The ubiquitous tRNA modifications are highly
conserved in eukaryotes, and many have crucial roles in the yeast Saccharomyces cerevisiae and in human
health. Lack of any of several modifications in the tRNA body (outside the anticodon loop) results in growth
defects in S. cerevisiae, and is linked to neurological disorders in humans. We study the rapid tRNA decay
(RTD) pathway in S. cerevisiae, which targets a subset of mature tRNAs lacking any of four body
modifications, due to exposure of the 5' end to the 5'-3' exonucleases Rat1 and Xrn1. RTD also occurs in fully
modified tRNA variants with destabilizing mutations exposing the 5' end, and is inhibited in met22Δ mutants
due to accumulation of the Met22 substrate adenosine 3',5' bis-phosphate (pAp), which inhibits Rat1 and Xrn1.
As little is known about the biology of body modifications in other eukaryotes, we study the evolutionarily
distant yeast Schizosaccharomyces pombe, which diverged from S. cerevisiae ~600 million years ago and has
facile genetics and molecular biology. Using genetic selection and whole genome sequencing of multiple
suppressors of growth defects of body modification mutants, we found that each of two S. pombe body
modification mutants target decay of a subset of the hypomodified tRNAs by part, but not all, of the RTD
pathway, establishing conservation of the use of this pathway. We also found new interactions between body
modifications, the RTD pathway, the ribosome, and a major conserved stress response pathway (the human
integrated stress response pathway) in both S. pombe and S. cerevisiae. Our current study of S. pombe pus1Δ
mutants, lacking pseudouridine (Ψ), and S. pombe tan1Δ mutants, lacking 4-acetylcytidine (ac4C12), has also
yielded new insights. Preliminary results with the pus1Δ mutant show decay of one specific tRNA by the RTD
pathway that is responsible for its growth defect, and an unexpected connection between decay and a major
conserved pathway that is also linked to the human PUS1 disease phenotype. Preliminary results with the
tan1Δ mutants show decay of two tRNAs by the RTD pathway that is responsible for its growth defect, and an
unexpected connection between decay and a conserved nuclease not known to have this role. To follow up we
will: 1A) Analyze the biology of S. pombe pus1Δ mutants. 1B) Analyze the biology of S. pombe tan1Δ mutants.
Despite the importance of tRNA decay, remarkably little is known about the turnover rates of individual
wild type (WT) tRNAs or about cellular factors that influence these rates. In addition, little is known about
turnover of tRNA ends, although the 3' CCA ends of tRNAs are known to undergo constant repair to ensure
healthy growth, and are the focus of several regulatory pathways. To follow up we will 2) Determine tRNA end
repair rates and tRNA turnover rates of individual tRNAs, using metabolic labeling and mass spectrometry.

Public health relevance
PROJECT NARRATIVE Transfer RNAs (tRNAs) are critical for decoding messenger RNA during translation by the ribosome, where they insert their charged amino acid into the end of the growing peptide chain. The numerous tRNA modifications found in all organisms are critical for function and stability, are highly conserved in the yeast Saccharomyces cerevisiae and in humans, and are required to prevent poor growth in yeast and human neurological disorders and mitochondrial diseases. This project is directed toward study of critical tRNA decay pathways in S. cerevisiae and the evolutionarily distant yeast Schizosaccharomyces pombe, and study of tRNA turnover dynamics in wild type cells and cells lacking critical modifications, to understand factors that influence the population of tRNAs.